ULTRASTRUCTURAL IMMUNOCYTOCHEMISTRY OF LIPID METABOLISM IN CELLS AND TISSUE

Cholesterol is delivered to cells as cholesterol ester in low density lipoproteins. In normal cells, hydrolysis of cholesterol ester in lysosomes frees cholesterol which moves out of lysosomes to other intracellular sites and ultimately becomes incorporated into the cell plasma membrane. Defects in intracellular cholesterol transport pathways result in loss of homeostatic responses that regulate cholesterol synthesis, uptake and esterification. Niemann Pick type C disease (NP-C) is a genetic disorder in which LDL derived cholesterol accumulates intracellularly and does not elicit the homeostatic responses of normal cells. The most prominent abnormality in affected cells is an alteration of intracellular cholesterol trafficking resulting in the accumulation of LDL-derived cholesterol in lysosomes and the Golgi, leading to reduced rates of cholesterol esterification. The gene that is affected in human NPC disease was recently identified by positional cloning and named NPC1. The human NPC1 cDNA sequence predicts a protein of 1278 amino acids. Immunocytochemical studies localizing the NPC1 protein, combined with studies on clearance of endocytosed [14C] sucrose, in fibroblasts targeted a trafficking defect caused by mutations in NPC1 to a novel endocytic compartment proximal to cholesterol laden lysosomes. To elucidate important structural features of the NPC1 gene product we examined the ability of wild-type NPC1 and NPC1 mutants to correct the excessive lysosomal storage of cholesterol in CT60 Chinese Hamster Ovary cells (CHO cells with the NPC phenotype). The results showed that wild type cDNA corrected the cholesterol lipidosis, whereas mutations in tthe amino terminus and sterol sensing domain of the protein did not. Although mutant NPC1 was transported to the lysosomal surface this location did not result in egress of cholesterol from lysosomes. We conclude that NPC1 protein must enter the lysosomal core to affect mobilization of cholesterol from lysosomes to other cellular sites.